Statistical Consulting Service: Epidemiologic Research

Studies of the effects of environmental agents on human health are a vital part of the mission of the institute. As such studies are almost always observational rather than experimental, interpretation of the data is complex. Good statistical collaboration in all phases, including conception, design, analysis, and interpretation, is essential to the success of this work. During the current year, we were active collaborators on many projects. Included were studies evaluating biomarkers, examining health effects of various environmental or occupational exposures and drugs, and describing biology of several conditions.